Biobehavioral basis of knee osteoarthritis pain

Project Summary/Abstract.
Discovery and validation of strong candidate biomarkers and clinical endpoints for pain is urgently needed that
can be used to facilitate the development of non-opioid pain therapeutics from discovery through Phase II clinical
trials. Emerging research using a combination of biomarkers deliver individualized predictions about future brain
and body health. Our own findings suggest that behavioral chronic pain characteristics are associated with
multiple biological biomarkers where a greater pain burden is associated with accelerated detrimental biological
processes. However, prospective research is urgently needed to determine pain’s impact on the heterogeneity
of these biological processes within an individual to elucidate the underlying patterns of biological changes using
a biobehavioral perspective which is needed for predicting future health and to be able to use as clinical
endpoints for interventions. The proposed study will prospectively address biobehavioral factors (i.e., cognitive,
psychological, social and cultural) affecting the experience and interpretation of knee pain and physical function
across racial/ethnic groups over time. We will prospectively assess pain along with multiple biomarkers as
predictors of cognitive, psychological and physical functional progression among middle-aged and older non-
Hispanic Blacks and non-Hispanic Whites with knee pain and controls over a four-year study period. With strong
support from the University of Florida, our interdisciplinary project, using a comprehensive biobehavioral multi-
methods approach, we will be the first to prospectively determine the trajectory and interactions among pain,
biological biomarkers and multiple domains of function within race/ethnic groups in OA pain. Findings will
contribute towards increased understanding of pain and its biobehavioral basis, with the potential to reduce
race/ethnic group disparities and improve pain-related health and functional outcomes.

Public health relevance
Project Narrative Our recent cross-sectional findings suggest that chronic pain is associated with multiple biological aging biomarkers where a greater pain burden is associated with accelerated aging processes. Thus, the goal of the proposed study is to determine the brain and bodily aging mechanisms whereby pain prospectively impacts function in aging and whether these are different across racial/ethnic groups. Findings will contribute towards increased understanding of pain and biological aging processes, with the potential to reduce race/ethnic group disparities and improve pain-related health outcomes.